Admin-Core-001

ADMINISTRATIVE CORE SUMMARY
The IMPACT Center brings together a transdisciplinary team focused on optimizing EBP implementation for
youth receiving mental healthcare in low-resourced community settings. Our goal is to accelerate the reach and
impact of EBPs by partnering with stakeholders to develop methods and toolkits that address three challenges
to high-quality EBP implementation in these settings. The Administrative Core is designed to ensure that the
IMPACT Center functions effectively, has a scientific and public health impact that is greater than the sum of its
component parts, and transforms mental health care delivery. Led by Co-Directors Lewis and Dorsey, the Ad-
ministrative Core includes the Steering Committee, and two external groups that drive IMPACT Center Activities:
a Scientific Advisory Board and a Stakeholder Advisory Committee. These committees come together annually
to review IMPACT's progress and influence, provide input about priorities and future directions, and engage in
iterative refinement of IMPACT's methods and resources. The Administrative Core is motivated to address four
strategically developed aims to ensure that the Center has near-term impact on clinical practice, by optimizing
EBP implementation: (1) Maximize learning and impact, (2) Foster synergy and integration in the IMPACT Cen-
ter, research, and practice community, (3) Grow investigator capacity to apply practical implementation science
optimization methods and (4) Evaluate and iteratively improve our Center's impact. The Administrative Core for
the IMPACT Center provides programmatic oversight and support for iterative testing and refinement of IMPACT
methods in three exploratory projects and a pilot grant program. Through our yearly Deep Dives and Symposi-
ums, we will create dedicated opportunities for strategic future planning with our transdisciplinary team, stake-
holders, trainees, pilot leads, and external advisory board. Through the Administrative Core's coordinated activ-
ities, we will grow research capacity for optimizing EBP implementation across 5 levels: (1) mentoring for trainees
on our exploratory projects and (2) pilot projects (e.g., students/junior faculty working with IMPACT Faculty to
carry out project activities, and publish and present results); (3) partnerships with the Society for Implementation
Research Collaboration and the Implementation Research Institute to fund trainees, offer workshops, office
hours, site visits, and 1:1 mentoring; (4) in-person training for local programs, (5) wide dissemination for the
global community (e.g., MOOCs, toolkits). Our dissemination and outreach plan includes a public website with
content across four areas: general communication; project-specific materials, updates and findings; a relational
database or clearinghouse curating evidence and optimized strategies from our exploratory and pilot projects;
and our methods, toolkits, and web-based trainings. We focus dissemination and outreach on the practice com-
munity to ensure public health impact, including our own networks, practitioner-focused websites, conferences,
and an IMPACT mailing list. Our formative and summative evaluation plan affords careful tracking and refinement
of internal processes, with metrics that ensure research progress and impact, and public health benefit.
*IMPACT: IMPACT Assessment of Pathways for Implementation & Dissemination